DELAVIRDINE MESYLATE WITH ZIDOVUDINE VS ZDV ALONE IN HIV1 SUBJECTS

This study will test whether delavirdine in combination with zidovudine is safe and effective in the treatment of patients with the human immuno-deficiency virus infection.